The Discovery to Cure High School Internship Program (DTCHIP).

Enter the text here that is the new abstract information for your application.
All high school applicants seeking admission to Discovery to Cure High School Internship Program, regardless of race, ethnicity, or economic status, are given equal consideration for selection and participation.

Public health relevance
Our objective is to provide, through the Discovery to Cure High School Internship Program, high-quality research experience to qualified high school students, undergraduates and high school teachers, to expose them to the excitement and possibility of biomedical research careers, regardless of race, ethnicity, or economic status.